Translational Pulmonary Vascular Biology Program

PROJECT SUMMARY/ABSTRACT
The primary objective of this proposal is to continue our longstanding cardiopulmonary research training efforts
at the University of Colorado Anschutz Medical Campus (CUAMC). This program trains individuals with
doctoral degrees in either biological or medical sciences for successful academic careers. A multidisciplinary
team oriented approach to both mentoring and research training is emphasizing the integration of studies at
the molecular, cellular, tissue organ, and physiological (whole animals or human subjects) levels to permit
rapid bench-to-bedside translation of the work performed. We have continued to expand the focus of the
training program to include access to expertise in Bioengineering, Biomaterials, Regenerative Medicine,
Genomics and Metabolomics and Redox Biology. This expanded focus will enable us to involve outstanding
programs and investigators whose work is directly related to cardiopulmonary biology. Of the many training
grants at CUAMC, this is the only one specifically dedicated to pulmonary vascular biology. Our continuing and
long-term goal is that after 3 years of training the program's fellows will have acquired the professional skills to
be competitive for research and/or teaching positions and obtain their own extramural funds. Our records show
that we have achieved this benchmark. Our specific objectives are: 1) To attract and select talented and highly
motivated fellows who have a demonstrated interest in cardiovascular and pulmonary diseases. 2) To provide
trainee fellows with an intensive research experience in cardiovascular-pulmonary research with a focus on the
pathophysiological aspects of chronic pulmonary vascular disease and right heart failure, by pairing them with
mentors who are rigorously selected based on their qualifications and scientific area of expertise and placing
them in a collaborative, stimulating environment. 3) To enhance the scientific knowledge and critical thinking
abilities of the participating trainees by requiring a series of workshops/lectures on hypothesis formulation,
experimental design, reporting and presentation of scientific information, grant proposal preparation and hands
on experience in innovative molecular and cellular physiological approaches to cardiovascular-pulmonary
research. 4) To enhance multidisciplinary, collaborative approaches to research by requiring co-mentors and a
Team-oriented T-shaped Development for T-32 Trainees (T4) approach along with strong interaction with
Advisory Committees. 5) To ensure that Fellows acquire the necessary information to conduct research in an
ethical manner. 6) To help the trainees/scientists develop proficiency with a wide array of non-bench
professional skills necessary for biomedical research careers such as communication, leadership
development, and project management and professionalism.
The increasing national and international interest in pulmonary vascular biology, the expanded nature of our
program, and the excellent track record of training individuals from all backgrounds, including
underrepresented minorities, support our request for 6 postdoctoral trainees each year.

Public health relevance
PROJECT NARRATIVE A large number of human diseases can affect the structure and function of blood vessels in the lung. In fact, when diseases are complicated by increases in pressure in the lung blood vessels (lung vascular disease), significant increases in morbidity and mortality are observed, which are often due to dysfunction or failure of the right heart. This program is directed at training individuals to better understand the causes of lung vascular and right heart disease with the long-tem goal that these investigators will develop new therapies to decrease or ameliorate the health burden of lung vascular problems.